ASSESSING HIV TESTING AND TREATMENT IN INDONESIA - NIAID/DCR

The overall prevalence of HIV in Indonesia is estimated to be less than 1%. However there are provinces where the prevalence is as high as 2.5%. The Indonesian Ministry of Health is concerned about the steady incidence rate in the country at about 21,000 new cases/year based on reported data. To target this, Indonesia will begin to “Test and Treat” HIV in 8 of the 33 provinces. These 8 provinces will receive testing for approximately 1.2 - 1.8 million individuals in high-risk groups (e.g., pregnant women, prisoners, homosexual individuals etc.).